Biology of terminal R-loops in splicing factor mutant cancers

This resubmitted R03 application seeks to determine how recurrent mutations common in splicing factors (SF)
lead to changes in chromatin accessibility and epigenetic landscape, thereby contributing to oncogenesis.
Recurrent mutations in SF are prevalent across multiple unrelated cancer types including acute myeloid
leukemia, chronic lymphocytic leukemia, lung cancer and melanoma. Among the hundreds of splicing factors,
only 4 are commonly mutated: SF3B1, SRSF2, U2AF1 and ZRSR2. SF mutations are mutually exclusive and
non-synonymous, suggesting their role as tumor drivers with neomorphic function. Their well-established roles
in splicing catalysis have led to the presumption that alternate splicing of tumor suppressors or oncogenes is
the primary mechanism driving clonal evolution of mutant cells. While alternate splicing events are
demonstrable in RNA-seq datasets, such changes are quite modest and restricted to specific mutational
subtypes. This makes a direct role of alternative splicing in oncogenesis questionable. Recent studies have
looked at alternate molecular mechanisms of oncogenesis including excess R-loops that arise in response to
mutant SF expression. R-loops are 3 stranded structures of two DNA and one RNA molecules formed during
transcription. R-loops are critical regulators of chromatin states, and when unchecked can lead to genome
instability. These R-loops also cause S-phase arrest and can be rescued by the over-expression of RNAseH.
Emerging evidence points to the close coordination between spliceosomal machinery and messenger RNA
processing, including its 3' end cleavage and termination. We hence hypothesize that terminal R-loops arise
from defective mRNA processing. In the first aim of this proposal, we will determine dynamics of transcription
in SF3B1 and U2AF1 mutations through metabolic labeling of nascent RNA (transient transcript sequencing
with Timelapse chemistry or TT-TL-seq). Location of RNA Polymerase II in relation to R-loops and stalled
DNA replication forks will be determined through proximity ligation assay. The second aim will explore how
epigenetic modifiers regulate the formation and resolution of such pathologic R-loops. Our preliminary results
using a short hairpin RNA library reveals the role of histone deacetylase pathway in this regulation; hence we
will explore the relation between HDAC and R-loops in this aim. Finally, we will determine chromatin
accessibility in splicing factor mutant acute myeloid leukemia patient samples, since R-loops and open
chromatin are highly correlated. Given the limited scope of the R03 mechanism, the proposal is primarily
focused on biochemical studies linking aberrant RNA processing and R-loop formation. If successful, it will
form the basis of comprehensive investigations into the mechanisms of oncogenesis conferred by SF
mutations utilizing appropriate in vivo models.

Public health relevance
Mutations in proteins that regulate cutting and rejoining of RNA (called RNA splicing) are common in many cancers, but the mechanism by which they cause cancer are unclear. We seek to determine defects in messenger RNA processing caused by these mutations. Our results can help inform development of novel therapies for these cancers.